NC A&T ESTEEMED Program

Abstract
North Carolina Agricultural and Technical State University (NC A&T) submits this new
ESTEEMED application with the overarching goal to significantly increase the preparation and
production of high achieving underrepresented minority students who will pursue careers in Ph.D.
programs in bioengineering or STEM fields relevant to Bioengineering. Consequently, the NC
A&T ESTEEMED program will employ a persistence framework that combines an academic
support system, early research experiences, collaborative learning and intrusive advising to
cultivate the science identity of underrepresented minority students. Specific aims for the NC
A&T ESTEEMED program are: 1) Increase the number of students who successfully complete
pathway courses by the end of the sophomore year; 2) Increase the number of students prepared
and committed to conduct research; and 3) Increase the number of students who are prepared
for entering Ph.D. level programs in Bioengineering or STEM fields relevant to Bioengineering.
Activities that support these aims and expected outcomes include: a Summer Bridge Program;
Academic Year Activities that include intrusive advising, academic support, faculty-directed
research, seminars; and, summer research experiences. Threaded through the two-year
program, the NC A&T ESTEEMED scholars will participate in activities that enhance their STEM
knowledge base, oral and written communication skills, and bioengineering/biomedical research
skills. The expected outcomes and expectations for this program are that 1) 80% of participants
will successfully complete freshman and sophomore level requirements for the major within two
years; 2) 100% of participants will meet research development goals; and 3) 80% of ESTEEMED
scholars will self-identify as a bioengineer or biomedical scientist.

Public health relevance
Narrative The ESTEEMED program at North Carolina Agricultural and Technical State University (NC A&T) will significantly increase the production of high achieving graduates who pursue advanced degrees in the biomedical sciences and diversify the STEM workforce. The program will use a persistence framework that combines an academic support system, early research experiences and mentoring, collaborative learning, and intrusive advising to cultivate the science identity of underrepresented minority students. The implementation of the goals, objectives and aims of the NC A&T ESTEEMED program will produce a stream of minority Ph.D. bioengineers and biomedical scientists who will address biomedical issues through the development of new and innovative technologies and cutting-edge research.